Intestinal Mucosal Protection by epidermal Growth Factor

Epithelial tight junction (TJ) is the primary component of intestinal mucosal barrier function that prevents diffusion of toxins, allergens and pathogens from the gut lumen into mucosa and eventually to systemic circulation. Disruption of TJs and permeability to injurious factors is associated with many gastrointestinal (GI) diseases, including radiation-induced GI syndrome (RIGS). Therefore, understanding the structure and regulation of TJs is essential to our understanding of the pathogenesis of many GI diseases and design of therapeutic strategies in treatment of the diseases. Occludin is one of the transmembrane proteins of TJs, the expression and distribution of which is altered in many GI diseases. The precise function of occludin is unclear. Out studies so far have identified a phosphorylation hotspot in the C-terminal domain of occludin, which we named as “Occludin Regulatory Motif (ORM)”. Our preliminary studies show that ORM may be required for regulation of TJ integrity by interacting with specific proteins, such as MAP7, especially during radiation-induced injury. Our preliminary data also show that probiotic, Lactobacillus casei (L. casei) attenuates radiation-induced barrier dysfunction by a mechanism involving epidermal growth factor receptor (EGFR) tyrosine kinase activity. On the basis of above information it is hypothesized that: a) “Occludin Regulatory Motif (ORM)” plays a role in regulation of tight junction dynamics in the intestinal epithelium, b) occludin- MAP7 interaction, mediated by oxidative stress and JNK2-cSrc signaling, plays a role in radiation- induced TJ disruption in the intestinal epithelium and c) oligopeptide factor produced by Lactobacillus plantarum attenuates radiation-induced tight junction disruption by an EGF receptor-dependent mechanism. Using both mouse models and Caco-2 cell monolayers we will determine that: 1) ORM is required for regulation of occludin mobility and tight junction dynamics, 2) Regulatory proteins interact with ORM by a phosphorylation-dependent mechanism, 3) ORM-MAP7 interaction regulates TJ dynamics by a phosphorylation-dependent mechanism, 4) ORM-MAP7 interaction is involved in radiation-induced TJ disruption and barrier dysfunction, 5) Oxidative stress and JNK2-cSrc signaling mediate radiation-induced alteration of ORM-MAP7 interaction and TJ disruption, 6) L. plantarum soluble factor attenuates radiation-induced tight junction disruption by suppressing oxidative stress, JNK2-cSrc signaling and occludin-MAP7 interaction, 7) EGF receptor transactivation is involved in L. plantarum-mediated TJ protection from radiation, and 8) Oligopeptide factor in L. plantarum is responsible for epithelial protection from radiation injury. Out come of these studies will open a new mechanism in epithelial tight junction regulation and therapeutic strategies for treatment of RIGS.

Public health relevance
On the basis of our recent publications and our preliminary data we hypothesized that occludin and its regulatory motif play a crucial role in regulation of tight junction in the intestinal epithelium under physiologic and pathophysiologic conditions. We propose to conduct studies to establish that regulatory region of occludin interacts with specific proteins such as MAP7 by a phosphorylation-dependent mechanism, and this interaction is required for occludin dynamics and TJ regulation. We plan to conduct studies to demonstrate that such occludin-regulated process is involved in radiation-induced intestinal mucosal barrier dysfunction, and this can be prevented by Lactobacillus plantarum soluble factor.